Machine-Learning Prediction and Reducing Overdoses with EHR Nudges (mPROVEN)

The US continues to grapple with an opioid epidemic, with ~69,700 opioid overdose deaths in 2020. Health
systems have instituted multiple interventions to reduce patient risk, many focusing on decreasing unsafe
opioid prescribing among those viewed as high-risk. However, there are limited tools to identify who is truly at
high risk of overdose, leading to burdensome interventions targeting an overly broad population or missing key
high-risk individuals. Even if those who are at risk can be identified, the interventions lack effective strategies to
change clinician behavior, focusing instead on blunt tools to reduce prescribing rather than reduce risk.
In prior work, we developed and externally validated machine-learning algorithms that identify patients at high
risk of opioid overdose, even if not actively prescribed opioids. Separately, we demonstrated how behavioral
nudge alerts embedded in the electronic health record (EHR) can be combined with risk prediction tools to
change clinician behavior. In this project, we propose to reduce opioid overdose risk by bringing together
machine-learning based overdose risk prediction and behavioral nudges through a scalable EHR intervention
to improve clinician prescribing behavior. In a large academic health system (UPMC), we propose the following
specific aims: (1) Incorporate our previously validated machine learning algorithm into the EHR to predict 3-
month risk of opioid overdose; (2) Pilot test a clinician-targeted behavioral nudge intervention in the EHR for
patients at high predicted risk for opioid overdose; (3) Evaluate the effectiveness of providing risk scores in the
EHR with and without a behavioral nudge to improve opioid prescribing safety and reduce overdose risk.
In Aim 1, we will apply our gradient boosting machine overdose prediction algorithm to the UPMC Epic-based
EHR. We will optimize the algorithm for use in UPMC primary care practices, addressing model accuracy and
algorithmic biases. In Aim 2, we will combine the risk score generated by our algorithm with clinician nudges in
the EHR, using a 3-phase pilot with focus groups, silent testing, and live testing in 3 primary care practices.
The nudge intervention will target clinicians caring for high-risk patients and will use active choice prompts for
naloxone and accountable justifications for opioid and benzodiazepine prescribing. In Aim 3, we will conduct a
cluster randomized trial in 45 UPMC primary care practices, with 3 arms: (1) usual care; (2) EHR-embedded
risk score; 3) EHR-embedded risk score coupled with the nudge from Aim 2. The EHR-embedded risk score
arm will consist of an alert in the EHR that identifies the patient as high risk for overdose. In the risk score
coupled with nudge arm, a similar EHR alert about high-risk status will flag, along with the nudges from Aim 2.
The primary outcome will be a composite of 3 prescribing practices associated with reduced risk of overdose:
naloxone prescription, opioid dosage <50MME per day, and no opioid/benzodiazepine overlap.
Our proposal builds on our prior NIDA-funded work and experience with nudge interventions and is aligned
with NIDA’s strategic goals to develop and test novel strategies for preventing opioid misuse and overdose.

Public health relevance
The US continues to grapple with an opioid epidemic, with close to 70,000 opioid overdose deaths in 2020. This project will test whether combining machine-learning based overdose risk prediction tools with simple behavioral ‘nudge’ interventions in the electronic health record can improve clinician prescribing behavior to reduce overdose risk. If successful, the project will demonstrate how risk prediction can help target low cost and scalable interventions to reduce overdose risk, opening the door to larger scale implementation and substantial public health benefit.